IMAGING OF RETROGRADE AND ANTEGRADE PULMONARY ASPIRATION

The investigators establish a three-day protocol looking at both antegrade and retrograde aspiration of technetium 99-m sulfur colloid labeled milk meal. It is anticipated that this research will establish normal standards for a new adult examination intended to detect retrograde pulmonary aspiration and distinguish this condition from antegrade aspiration.